High Resolution Models of Groundwater Metal Exposures

Project 1 Summary
The long-running Strong Heart Study documented high urinary arsenic (As) and uranium (U) levels in Native
American tribal study sites relative to the general US population. Elevated exposures to metals and metalloids
(hereafter metals) potentially contribute to the epidemic of cardiometabolic disease affecting tribal and other rural
communities in the US. In rural communities of the Northern Plains, drinking water is commonly derived from
unregulated and largely unmonitored private wells or public water systems that draw from the same aquifers.
Much of the As and U exposure likely results from elevated levels of metals in groundwater sources. However,
groundwater data are relatively scarce for rural communities, especially from tribal regions, making it difficult to
identify groundwater hazards, and to mitigate their exposures. Project 1 of the Columbia University Northern
Plains Superfund Research Program (CUNP-SRP) uses a two-pronged approach to address a critical gap in our
understanding of the distribution of groundwater contamination and exposure across rural areas including Native
American tribal areas. First, we will integrate existing and new measurements of groundwater composition data
with prior large mineralogical and chemical speciation data sets. Second, we will use a combination of
groundwater composition in wells and remotely sensed hydrological and other variables to develop machine
learning-based predictive models of groundwater contaminant levels at the household scale—the foundational
data needed for exposure assessment. We have 3 specific aims. Aim 1 will analyze drinking water sources from
the CUNP-SRP field areas to identify and better understand the mobilization mechanisms of As and U into
drinking water. Aim 2 will develop process-based models that predict As and U drinking water concentrations at
the household scale across the Northern Plains. Aim 3 will develop and validate As and U drinking water
exposure profiles for the Strong Heart Arsenic and Uranium Lifelong (SHAUL) cohort (for Project 3) by comparing
spatial and temporal variability and trends in water metal concentrations, water use, and detailed residential
histories with urinary-based exposures for tribal participants from all SHAUL locations. We will also evaluate the
impact of policy interventions on drinking water As and U exposures, including those from changes in water
sources and use, implementation of As MCL on contaminant concentrations in CWSs, and implementation of
point-of-use filtration. Combined, our data and models will provide improved understanding of environmental
exposures that is needed for the CUNP-SRP to contextualize the health effects of hazardous metal mixtures
(Projects 3 and 4), to identify mitigation pathways to clean water (Project 5), and to allow the Community
Engagement and Administrative Cores to make the environmental data and their interpretations accessible to
these tribal communities. Ultimately, the results of these efforts in data collection, modeling, and additional data
analysis will help identify at-risk populations and develop effective interventions to reduce potentially dangerous
exposures to contaminated drinking water in the Northern Plains and beyond.

Public health relevance
Project 1 Narrative There is a lack of groundwater data in Northern Plains Native American tribal communities despite groundwater being the most likely source of exposure contributing to high urinary arsenic and uranium levels in these communities. Project 1 will merge new measurements of drinking water quality with existing spatial datasets to develop process-based models that predict contaminant concentrations at the household scale across Northern Plains tribal sites. The results, together with evaluations of temporal changes in drinking water concentrations from prior policy interventions and development of drinking water exposure profiles for the study cohort, will enable the development and establishment of effective interventions to reduce these potentially hazardous exposures to contaminated drinking water in the Northern Plains and beyond.